FORMATION OF NITROSYL MYOGLOBIN IN ISOLATED HEARTS DURING CARDIOPLEGIC ISCHEMIA

Myocardial tissue is enriched with myoglobin, which exists predominantly as oxymyoglobin under aerobic conditions. During ischemia, deoxymyoglobin accumulates due to decreased oxygen concentration. Nitric oxide has a very high affinity for deoxymyoglobin and forms nitrosylmyoglobin (MbNO), which can be detected by electron spin resonance (ESR). Previously, it has been shown nitric oxide donor S-nitrosoglutathione (GSNO) improves the postischemic functional recovery in crystalloid buffer-perfused isolated rat hearts subjected to cardioplegic ischemia. Supplementation of cardioplegic solution with nitronyl nitroxide, a scavenger of nitric oxide, antagonized this protective effect. Using low temperature ESR, we have detected MbNO in rat hearts subjected to cardioplegic ischemia in the presence of GSNO (20-200 fmol/l). Nitronyl nitroxide (400 fmol/l) prevented the formation of MbNO induced by 20 fmol/l GSNO during ischemia. During aerobic reperfusion, MbNO signal intensity gradually decreased, but persisted for up to 30 min or aerobic reperfusion. We conclude that MbNO is a sensitive intracellular marker of nitric oxide release in myocardial tissues. Implications of MbNO formation are discussed with respect to cardioprotection during ischemia- and reperfusion-induced myocardial injury.